Dorsal striatal phosphodiesterase 10A and compulsive ethanol use

ABSTRACT
Alcohol use disorder (AUD) is a chronic, relapsing disorder that afflicts 29% of Americans in their lifetime1,2,
is disabling2 and increases mortality3. New drug targets and neurobiological insight for AUD are needed.
Guided by preliminary data, this administrative supplement seeks to expand studies of gene variants in
phosphodiesterase 10A (PDE10A) performed in the UK Biobank (and related phosphodiesterases, adenylyl
cyclases and protein kinase A-related proteins that regulate alcohol-related cAMP cascades) to studies in the
ethincally and socioeconomically diverse All of Us dataset. Specially, Aim 1 will use both genotyped arrays
and whole genome sequence datasets to identify PDE10A gene variants that associate with problematic
alcohol use, as defined by AUDIT-C scores and alcohol use-associated diagnoses, as well as their expression
and genetic correlation to often comorbid psychiatric and obesity-related diagnoses. This administrative
supplement will increase the impact of the parent grant to identify novel gene variants in PDE10A and other
cAMP-cascade regulating genes towards repurposing novel translatable PDE inhibitors to treat AUD. The
supplement will increase the sensitivity and generalizability of genetic discovery to reflect the age, ethnic, and
socioeconomic diversity of the American population. Extending our analyses to the All of Us dataset is pressing
given the known role of inequitable social determinants of health, interacting with genetic factors, in alcohol-
related morbidity and comorbidity within the United States.

Public health relevance
NARRATIVE Alcohol use disorder (AUD) is a chronic, relapsing, prevalent, disabling and fatal disorder for which new drug targets and neurobiological insight are needed. Guided by preliminary data, this this administrative supplement seeks to expand studies of gene variants in phosphodiesterase 10A (PDE10A) performed in the UK Biobank (and related phosphodiesterases, adenylyl cyclases and protein kinase A-related proteins that regulate alcohol-related cAMP cascades) to studies in the ethincally and socioeconomically diverse All of Us dataset The supplement will increase the impact of our genetic discovery to reflect the age, ethnic, and socioeconomic diversity of the American population and seeks to redress the known role of inequitable social determinants of health, interacting with genetic factors, in alcohol-related morbidity and comorbidity in the United States.